Visualizing the divergent conformational dynamics of KCNH channels

Project Summary
The KCNH channel family includes both the Human ether á go-go related gene (hERG, KCNH2) potassium
channel that is expressed in the heart and responsible for repolarizing the action potential and, the mammalian
ether á go-go gene (EAG, KCNH1) potassium channel is expressed in neuronal tissue and contributes to
electrical excitability. The role of hERG in cardiac health is well studied and mutations in hERG cause Long QT
type 2 syndrome. Comparatively, the physiological role of EAG is relatively unstudied, yet human EAG is over
expressed in many types of cancer and newly identified genetic mutations are linked to epileptogenic Temple-
Baraitser and Zimmerman-Leband syndromes. Additionally, although EAG is inhibited by calcium sensor
proteins CaM and S100B, the stoichiometry, calcium occupancy and cooperativity remain to be uncovered.
While hERG and EAG channels share high sequence similarity, domain topology, and structural similarity they
have highly divergent gating kinetics and regulation. We hypothesize that each KCNH channel has divergent
and distinct gating dynamics that give rise to unique channel kinetics to tune individual channels for their precise
physiological roles and these dynamics are altered by physiologically relevant effectors. In this proposal we
measure and model the dynamics of the structurally solved KCNH channels hERG and EAG. We use non-
canonical amino acids (ncAA) as small genetically encoded non-perturbing probes to study channel dynamics.
We examine the characteristic slow deactivation of hERG that has been partially attributed to voltage dependent
potentiation (VDP) and manifests as a hyperpolarizing shift in the voltage dependence of deactivation compared
to activation. VDP is reduced in response to lowered extracellular pH which can occur during acute disease
states and accelerates hERG deactivation. We incorporate the fluorescent ncAA 3-[(6-acetyl-2-
naphthalenyl)amino]-L-alanine (L-ANAP) in hERG and use transition metal Förster resonance energy transfer
(tmFRET) to measure dynamic motions at 10-20Å resolution to measure hERG VDP dynamics and examine
how it is altered by pH. We will use distances obtained from tmFRET as constraints to visualize VDP in hERG
with Rosetta modeling. We then examine the role of the highly conserved KCNH intrinsic ligand motif (IL) in
EAG kinetics. In EAG, mutations in the IL alter channel kinetics to slow activation and abolish the Cole-Moore
shift. We incorporate the photo-crosslinkable ncAA 4-benzoyl-L-phenylalanine (BZF) at the IL and use ultraviolet
light to examine the loss of EAG IL dynamics on channel kinetics. Finally, with a traditional FRET approach we
aim to determine the conserved nature of calcium sensor protein regulation of EAG and examine if mutations
linked to TB/ZL syndromes alter EAG calcium regulation as it is unclear if calcium dependent channel inhibition
is lost in disease states. Due to the roles of hERG in cardiac excitability and arrhythmia, and EAG in TB/ZL and
cancer, determining the dynamic gating mechanisms of these channels directly impacts health and disease.

Public health relevance
Narrative Genetic mutations in the KCNH family of potassium ion channels cause Long QT syndrome type 2 (LQTS2), or Temple-Baraitser (TB) and Zimmermann-Leband (ZL) diseases. LQTS is a heart rhythm disorder that can cause fast erratic heartbeats which can trigger sudden death, whereas TB and ZL diseases cause developmental abnormalities and seizures. Our research is aimed at identifying, measuring, and modeling the unique KCNH channel dynamics providing vital insight into these disorders, and to aid in developing effective therapeutic targets.